Synaptic and dendritic physiology in the prefrontal cortex

PROJECT SUMMARY
Interactions between the thalamus and prefrontal cortex (PFC) are important for cognitive function in animals
ranging from rodents to primates. The importance of these long-range networks is highlighted by multiple
neuropsychiatric diseases, including schizophrenia and ADHD. However, most of what we know about
thalamo-cortical circuits comes from sensory systems, where primary thalamic inputs arrive in layer 4 (L4). In
contrast, the mouse PFC is an agranular area that lacks L4, and instead receives higher-order thalamic inputs
directly to superficial layers. We recently discovered that the PFC makes reciprocal connections with both the
mediodorsal (MD) and ventromedial (VM) thalamus. These thalamic nuclei support distinct behaviors, but the
cellular, synaptic and circuit mechanisms for their interactions with PFC are poorly understood. We found MD
strongly drives layer 2/3 (L2/3) pyramidal cells, whereas VM inputs contact the dendrites of a subset of L5
pyramidal cells. Interestingly, both inputs also robustly engage inhibitory networks to drive local inhibition
mediated by GABAergic interneurons. The goal of this proposal is to assess how thalamic inputs engage
different populations of superficial interneurons to mediate inhibition in the PFC. In Specific Aim 1, we use
optogenetics and electrophysiology to study how thalamic inputs drive multiple classes of interneurons in
superficial layers. Our preliminary data suggests that MD and VM engage complementary populations of
interneurons located in different sub-layers. In Specific Aim 2, we then use conditional optogenetics to study
how these interneurons contact excitatory and inhibitory cells within and across layers. Our preliminary data
indicate that the interneurons contacted by MD and VM participate in distinct inhibitory and disinhibitory circuits
across multiple layers. Lastly, in Specific Aim 3, we combine 1-photon optogenetics with 2-photon microscopy
to study how specific populations of interneurons mediate the suppression of dendritic Ca2+ spikes. Our
preliminary data reveal that a sub-population of superficial interneurons mediates robust feed-forward inhibition
in the dendrites. Together, the results from our experiments will answer fundamental questions about the
organization of thalamo-cortical circuits and interneurons in the PFC. They will also help identify potential
therapeutic targets for the many neuropsychiatric disorders that arise from disrupted circuitry within the PFC.

Public health relevance
PROJECT NARRATIVE Our goal is to determine how higher-order thalamus interacts with different populations of GABAergic interneurons to mediate inhibition in the mouse prefrontal cortex (PFC). Using a combination of electrophysiology, optogenetics and 2-photon microscopy, we will examine how two thalamic inputs interact with a variety of interneurons, how these cells synapse onto other excitatory and inhibitory cells, and how a subset of interneurons contacts the dendrites to inhibit local Ca2+ signaling. Our experiments will help elucidate how the thalamus interacts with the PFC to support cognitive function and how this may go awry in mental health disorders.